Career Enhancement Core

Career Enhancement Core
ABSTRACT / PROJECT SUMMARY
The Career Enhancement Core (CEC) of this U54 Application proposes an integrated set of educational and
research support activities to foster development of research at UCLA in women's health and sex as a
biological factor in disease (WH/SABV), especially related to sex differences in the metabolic syndrome. The
project will support a pilot and feasibility grant program, to provide seed funding each year to novel research
projects that investigate WH/SABV, attracting new junior and established investigators to this area and
fostering their professional development. The CEC will support novel educational programs at UCLA, aimed at
every level of the university, especially undergraduates, but also including doctoral students, residents and
fellows, and young and established faculty. A new program is proposed “Introduction to SABV Research
Concepts and Methods” to develop early-stage undergraduates and recruit them to SABV research. A core
advanced undergraduate course will be taught, “Sex Differences in Physiology and Disease”. New lectures on
diverse topics related to SABV will be videotaped and streamed from the online UCLA SABV Video Library, to
enhance education on SABV internationally. CEC faculty will consult extensively one-on-one with established
investigators who are learning best practices for embarking on research in SABV in animal models of disease.

Public health relevance
Career Enhancement Core NARRATIVE The Career Enhancement Core (CEC) will provide an integrated set of educational and research support activities at UCLA to foster development of research at UCLA in women's health and sex as a biological factor in disease (WH/SABVD), especially related to sex differences in the metabolic syndrome. Among the activites of the CEC are a Pilot and Feasibility pilot grant program for UCLA investigators, teaching early-stage and advance undergraduate SABV courses at UCLA, producing the UCLA SABV Video Library streaming videotaped lectures on SABV for free distribution worldwide, and programs to recruit under-represented minority students to research in this field.